Supplement of NIDDK R01 newer GLDs and Clinical Outcomes

PROJECT SUMMARY/ABSTRACT
In our parent award R01 DK133465, we leverage real-world data (RWD) from the OneFlorida+ Clinical Research
Consortium to identify clinically high-benefit patient subgroups for newer glucose-lowering drugs and generate
economic evidence for designing policy-level interventions to improve the quality of care and health equity in
type 2 diabetes (T2D) care. OneFlorida+ contains ~20 million patient EHRs across Florida, Georgia, and
Alabama, linked with data from various other sources, including Medicaid and Medicare claims. We are making
progress on (1) developing research-grade computable phenotype algorithms for identifying “loyal patients,”
defined as those with medical encounters and drug exposure fully documented in EHRs; (2) identifying clinically
high-benefit patient subgroups for newer GLDs; and (3) refining our diabetes microsimulation model to generate
economic evidence for designing policy-level interventions to improve the quality of care and health equity in
T2D care. In our renewal application, we aim to construct digital twin models of T2D that consider not only
clinical characteristics but also the multifaceted social determinants of health (SDoH) to support the integration
of social care into health care delivery. Nevertheless, AI/ML-based digital twin models are computationally
complex and data-hungry, requiring to make large amounts of real-world patient data AI/ML-ready.
In this administrative supplement, in Aim 1, we will develop pipelines and associated documentation to (a)
standardize RWD data into a common data model with a focus on the SDoH, and (b) make the RWD into AI/ML-
ready datasets, in preparation for the development of T2D digital twin models. Built on our T2D simulation model,
we will systematically identify additional factors, with a focus on SDoH, that would significantly affect individuals’
quality of care and adverse outcome, and develop pipelines to extract-transform-load (ETL) from the OneFlorida+
EHR data into the widely adopted Observational Medical Outcomes Partnership Common Data Model (OMOP
CDM). In Aim 2, we will evaluate the potential bias of AI/ML models developed with different degrees of EHR
data completeness. A common practice in building AI/ML models using RWD is to select only patients that have
more complete data, which may introduce bias. We will systematically assess the downstream AI/ML model
bias using algorithmic fairness metrics, which is critical for our future development of a fair T2D digital twin.
This project will make the data generated from our NIDDK-supported project AI/ML-ready and respond directly
to NOT-OD-23-082, where we will (1) prepare “SDoH information for use in AI/ML” and adopt “ontologies or other
standards to improve interoperability,” (2) characterize “biases that may affect AI/ML model trained on the data,”
and (3) develop “documentation for or AI/ML re-users of the data.” With the success of this administrative
supplement, we will be well-positioned to develop digital twin models of T2D, considering not only clinical
characteristics but also multifaceted SDoH to support the integration of SDoH management into the clinical care
of T2D, leading to a paradigm shift in the US health care delivery.

Public health relevance
PROJECT NARRATIVE: PUBLIC HEALTH RELEVANCE The digitalization of real-world data (RWD) combined with the advancements in artificial intelligence (AI) and machine learning (ML) offer untapped opportunities to generate real-world evidence (RWE) to improve diabetes care and outcomes. Our overarching goal is to improve health outcomes and equity for patients with type 2 diabetes (T2D) by establishing an AI/ML-based digital twin of T2D along with a dynamic learning health community. In this project, we aim to build AI/ML ready data for developing the digital twin of T2D, considering clinical, social, and environmental factors associated with T2D.